Shared Resource Management

PROJECT SUMMARY/ABSTRACT
Access to effective, state-of-the-art Shared Research (SR) facilities to support experimental goals and projects
is a critical need for cancer investigators performing basic, translational, and clinical research. The overall goal
of the SRs supported by the Holden Comprehensive Cancer Center (HCCC) is to provide essential
technological support and expert advice to enhance the effectiveness and positive impact of HCCC member
research. These SRs also provide ongoing advice and education that encourages and facilitates investigator
exploration of new developments in technologies, experimental approaches, and data analysis. Although
focused upon SR-specific services and mechanisms to accomplish this goal, each SR is designed to achieve
this objective. Leadership of the HCCC coordinates closely with collegiate and university administration to
ensure that the specific SRs most needed by HCCC researchers are accessible and adequately supported.
Oversight is exercised by close and regular interaction of HCCC leaders with SR Directors and technical
managers, feedback from HCCC member users, and advice from the HCCC External Advisory Board. This
ensures clear understanding by the leadership of SR goals, challenges, and future directions, as well as
appreciation by SR Directors of HCCC member needs, and how the SRs can best effectively address these
needs. SR goals are addressed via three specific aims: 1) assure SRs have appropriate polices governing their
use, including member accessibility, 2) monitor current and future needs of HCCC members, including
appropriateness and quality of SR services, and access to technologies and expertise, and 3) work with HCCC
members and the institution to identify and support new SRs, new capabilities for current SRs, and new
approaches to optimize SR support for cancer research. The nine HCCC-supported SRs proposed for the
requested funding period are Biostatistics, Central Microscopy, Flow Cytometry, Genomics, High Throughput
Screening, Population Research, Radiation and Free Radical, and Viral Vector and the Biospecimens
Procurement and Molecular Epidemiology Resource.

Public health relevance
PROJECT NARRATIVE Not applicable